CXCR4: A potential therapeutic target in HSK

Herpes stromal keratitis (HSK) is a leading cause of infection-induced vision loss in the United States. The HSK
develops in response to corneal herpes simplex virus-1 (HSV-1) infection. Recurrent corneal HSV-1 infection
can cause the persistence of innate immune cells, such as monocytes, neutrophils, and effector CD4 T cells in
the corneal stroma of the infected cornea. As the accumulation of neutrophils and effector CD4 T cells in the
HSK cornea plays a pivotal role in orchestrating the tissue damage, the strategies to manipulate the stay of
infiltrating immune cells in the HSK cornea are anticipated to have an effect in reducing the HSK severity.
Chemokine receptors, such as CXCR4, can play an important role in the retention of inflammatory cells in the
injured tissue. CXCR4 signaling is also reported to enhance hemangiogenesis in ischemic tissue. Our preliminary
results showed an increased expression of CXCR4 and CXCL12 in HSV-1 infected cornea. We recently
standardized a protocol to separate an intact corneal epithelium (CE) and corneal stroma (CS) from uninfected
and HSV-1 infected cornea. Single-cell suspension prepared from individual CE and CS can be used for flow
cytometry. Using this strategy, we detected the presence of CXCR4-expressing cells in uninfected CE of
C57BL/6 mice. Our results showed that most CXCR4-expressing cells in CE of naïve cornea display the
phenotype of Langerhans cells (LCs) or plasmacytoid dendritic cells (pDCs). Recently, monoamines have been
shown to engage CXCR4 on pDCs and inhibit IFN-a production. Histamine is a monoamine that is released
upon corneal HSV-1 infection. Experiments proposed in aim 1 will test the hypothesis that histamine released in
HSV-1 infected cornea engages CXCR4 on pDCs, and downplays IFN-a production from CE pDCs, increasing
viral load. Our results also showed that the number of LCs decreases in the CE but increases in the CS from 4-
day to 9-day post-infection (p.i.), suggesting a possible migration of these cells from CE to CS in HSV-1 infected
corneas. An increased expression of CXCL12 (CXCR4 ligand) was detected in CS than CE of the infected cornea
at 9-day p.i. Furthermore, most CD4+ T cells in the CS of infected cornea displayed effector (Ly6Chi) phenotype
at 9-day p.i. Experiments proposed in aim 1 will test the hypothesis that LCs-mediated restimulation of effector
CD4 T cells in the CS of the infected cornea is essential for their retention and effector function. Aim 1
experiments will also test whether LCs migrating out of CE and neutrophils infiltrating in the CE of HSV-1 infected
cornea impair corneal epithelial healing. In addition to corneal resident innate immune cells, our results also
detected the expression of CXCR4 on infiltrated neutrophils and vascular endothelial cells from newly formed
blood vessels in the CS of HSK cornea. Experiments proposed in aim 2 will test the hypotheses that blocking
CXCR4 signaling in HSK cornea will cause reverse migration of neutrophils and inhibit the development of
hemangiogenesis. The successful completion of the studies proposed in this application will underscore the
pleiotropic effects of CXCR4 signaling in HSK cornea and document it as a potential therapeutic target in HSK.

Public health relevance
Herpes stromal keratitis (HSK) occurs due to the growth of blood vessels and accumulation of neutrophils and effector CD4 T cells in the corneal stroma of the HSV-1 infected cornea. The proposed application will study the pleiotropic effects of CXCR4 signaling in promoting the retention of immune cells and hemangiogenesis in HSK.